Heat Waves, Pediatric Readiness, and Child Outcomes: Risk, Mitigation, and Resilience in Emergency Care

Proposed Approach: We will use data science and data integration across 13 different data sources to
study the intersection of climate change, children, and emergency care. The project will provide a
comprehensive evaluation of climate and health among children, with a focus on heatwaves. We will
use existing research infrastructure, weather data with detailed spatial resolution, geospatial analyses,
advanced analytics, modeling, and an interdisciplinary team to address this critical public health issue.
Importance: Children are vulnerable to climate change, yet the science of climate and health in children
is underdeveloped. We have recently shown that high emergency department (ED) pediatric readiness
is independently associated with improved survival, but the function of high-readiness EDs during
heatwaves is unknown. Addressing children in a changing climate is critical to their welfare, including
methods to mitigate adverse outcomes and ways the U.S. healthcare system can remain resilient. This
project is designed to inform EDs, hospitals, healthcare systems, and national health policy for children.
Objectives: There are three specific aims: Aim 1: Using the national assessment of ED pediatric readiness,
detailed weather data, pediatric census data, and geospatial analysis, we will identify the most geographically
vulnerable areas for children due to heatwaves that also lack access to high-readiness EDs. Aim 2: We will
create three national samples of children receiving emergency services (prehospital, EDs, and trauma centers)
to evaluate the association of heatwaves with excess mortality and healthcare utilization across millions of
children. Aim 3: Using two longitudinal pediatric cohorts, we will assess whether high-readiness EDs mitigate
excess mortality during heatwaves and are resilient in their known survival benefit.
Study Design & Setting: We will build three large samples of children using emergency services from 1/1/2012
to 12/31/2023 during the “warm season” (May to September), including 9-1-1 responses from over 14,000
emergency medical services (EMS) agencies (the Prehospital Sample), ED visits to 1,856 EDs across 16 states
(the ED Cohort), and admissions to 999 trauma centers across the U.S. (the Trauma cohort). To assess
access to high-quality emergency care, we will estimate the driving time to 4,840 EDs across the U.S.,
combined with their level of pediatric readiness. For weather data, we will use a 1 x 1 kilometer spatial
resolution for heatwaves (defined as average daily temperature ≥ 95%ile for ≥ 2 days), air quality (fine
particulate matter), humidity, and greenspace (Normalized Difference Vegetation Index).
Participants: Children 0–17 years using emergency services, including 4.9 million 9-1-1 EMS
responses, 53 million ED visits, 1.8 million hospitalizations, 29,527 deaths after ED presentation, plus
311,490 injured children admitted to US trauma centers and 4,517 deaths after injury.
Outcome measures: We will evaluate mortality (primary) and healthcare utilization among children.

Public health relevance
Project Narrative Because children are a vulnerable population, preserving their health during climate change is a public health priority. We will conduct a national geospatial evaluation of areas with frequent heatwaves and limited access to high quality emergency care, representing high-risk areas for children. We will also use national pediatric samples of 9-1-1 ambulance responses, visits at 1,856 emergency department (EDs), and admissions at 999 trauma centers to evaluate mortality and healthcare utilization during heatwaves and assess whether EDs with high pediatric readiness can mitigate adverse outcomes in children and prove resilient during these events.